0425SKB--HAVRIX VACCINE FOR HEP A IN HIV+ PATIENTS

To determine if Hepatitis A vaccine is safe in HIV - infected persons, and how well HIV - infected persons develop an immune (antibody) response to the vaccine.